New York City Consortium for Precision Medicine

The large-scale, multi-institutional nature of the All of Us Research Program depends on the ability to record
and share participant data accurately and securely via HealthPro. Each of the New York City (NYC)
Consortium institutions, Columbia University Medical Center (CUMC) and Weill Cornell Medicine (WCM), both
affiliated with New York-Presbyterian (NYP), and Harlem Hospital (HH), has a fully executed Interconnection
Security Agreement with Vanderbilt University Medical Center (see Appendix G), and have IT security
procedures consistent with the PMI Data Security Policy Priniciples and Framework and PMI Privacy and Trust
Principles. All of the NYC Consortium institutions have experience using HealthPro through multiple pre-launch
dry runs, as well as enrolling through both alpha and beta phases. Each of the three enrollment institutions has
two trained HealthPro Administrators to manage all HealthPro accounts at their respective institutions, and all
users are trained on the use policies as outlined in the HealthPro Acceptable Use Policy and, for privileged
users, Rules of Behavior for Privileged Users. Further, all staff who will be entering participant data into
HealthPro (e.g., physical measurements or biospecimen orders) are trained first in the HealthPro Test
environment enabling test entry of fake data, and then are further trained in the live HealthPro environment
through shadowing of established HealthPro users.

Public health relevance
No Text